Veteran Employment and Economic Security Research Consortium

Background and Significance: The Supporting Employment and Resources for Veterans’
Economic Security (SERVES) CORE will develop data infrastructure and a learning health
system community of researchers dedicated to studying employment and economic security for
Veterans to prevent negative downstream outcomes including homelessness, suicide, criminal
justice involvement, and poor health. SERVES will address the priority area of
housing/economic security/homelessness, is aligned with the VHA’s Strategic Plan, and will help
fulfill required activities per the Evidence-Based Policymaking Act. At the end of Year 5,
SERVES will operate a network of diverse researchers in various career stages, successfully
administer a multi-year pilot grant funding program, and have developed a body of operations-
partnered research that has improved understanding and development of programs that serve
the economic security of Veterans to improve their housing, health, and well-being.
Strategic Plan: The three major Goals of SERVES are to: 1) Increase Veterans’ access to
evidence-based programs and expand VA’s adoption of scientifically supported employment
services; 2) Foster research on the reciprocal effects of employment and medical/psychosocial
conditions, as well as the development and evaluation of programs to ameliorate the impact of
these factors; and 3) Create a robust network of early career and mid-career investigators
incorporating aspects of financial health that align with the needs and priorities of relevant
VACO partners. A number of activities are proposed to achieve these goals, including
developing a repository of best practices for employment and financial stability/health for
Veterans; forming a national research agenda on employment and economic security;
identifying outcomes measures that can be standardized across VA; compiling a database of
available datasets for researchers to analyze; and creating a mentoring program.
Innovation: SERVES would be the first concerted VA effort to create a network and
infrastructure for a learning health system focused on economic security, which is the root of
many social determinants of health. SERVES would help support the next generation of
researchers to focus on primary and tertiary prevention of homelessness.
Coordination, Collaboration, and Partnerships: SERVES will work with primary operational
partners in the VHA Homeless Programs Office and the VHA Office of Vocational Rehabilitation
Services; with secondary operational partners in the Office of Suicide Prevention, the National
Substance Use Disorders Office, the Office of Veterans Financial Resource Center, and VBA.
Research partners will include the QUERI-funded evaluation center, SALIENT, MIRECC, and
the HSR Center of Innovation, CHOIR.
Management Plan: The Contact PI will be Jim LePage, PhD based at VA North Texas Health
Care System who will lead Goal 1. Other Multiple-PIs will be Brian Stevenson, PhD based at the
VA Bedford Health Care System who will lead Goal 2 and Jack Tsai, PhD based at VA South
Texas Healthcare System who will lead Goal 3. All MPIs will work to support the three Goals.

Public health relevance
The Supporting Employment and Resources for Veterans’ Economic Security (SERVES) CORE will address the priority area of housing/economic security/homelessness. The ultimate objective of the SERVES is to support and sustain an active network of VA researchers focused on studying how to improve the employment and economic outcomes of diverse Veterans including those who are homeless, disabled, and have mental and substance use disorders. In shorthand, the first major goal of SERVES is adoption of best practices and successful programs, the second major goal is rigorous examination and standardization of outcomes, and the third major goal is a robust network of researchers in different career stages focused on this topic. SERVES will work with operational partners in VHA and VBA and work collaboratively with several existing QUERI and HSR Centers to achieve these goals.